Bioinformatics

CORE 2: BIOINFORMATICS INFRASTRUCTURE AND SERVICES SUMMARY The Bioinformatics Infrastructure and Services Core will support the three CCMI projects at all stages of research and publication. The core will be composed of three major components: Cytoscape and the Cytoscape Cyberinfrastructure (CI)? the Network Data Exchange (NDEx)? and the CCMI Data and Analysis Portal. First, Cytoscape will provide a range of tools for the analysis and visualization of biological networks, including the protein­protein interaction networks from ?Project 1?, the genetic interaction networks from Project 2?, and the hierarchical cancer cell ontologies and models from ?Project 3?. The second component, NDEx, will provide database infrastructure to support the sharing, review and dissemination of network data and models. It will also enable consolidated access to public biological network resources for use by CCMI investigators. Finally, the CCMI Data and Analysis Portal will provide a common access point for software tools and pipelines and for their associated data. This component will be supported by GenePattern Notebooks, which will facilitate the development of workflow pipelines and the sharing and reproducibility of analyses. The above three components — visual network maps in Cytoscape, storage of networks and models in NDEx, and software and analysis workflows in GenePatte? rn Notebooks — will all be made accessible through the CCMI’s website (ccmi.org). Publications using CCMI products will be enhanced by the recent additions to Cytoscape for dynamically embedding network data in peer­reviewed journals. Finally, the Core will draw on an impressive array of hardware infrastructure for supercomputing, including high performance clusters at multiple sites.